Corticofugal Circuits for Active Listening

Cholinergic basal forebrain (CBF) neurons project throughout the neocortex, hippocampus, and amygdala to
modulate perceptual salience and regulate synaptic plasticity underlying learning and memory. CBF research
has focused on rostral regions, including the medial septum, nuclei of the diagonal band, and nucleus basalis
(NB). The caudal extreme of the basal forebrain has been largely overlooked, yet our research suggests that
this caudal tail region – much like the tail of the striatum – can be conceptualized as a distinct functional
subdomain with categorically different response properties than more rostral regions. The projections of CBF
tail neurons (CBFt) are concentrated in two regions: the auditory cortex (ACtx) and the thalamic reticular
nucleus (TRN). Our published and preliminary recordings from CBFt neurons in passively listening mice reveal
surprisingly strong, short-latency, low-threshold responses to a broad class of auditory stimuli that have no
explicit behavioral relevance. Comparable responses are not observed for stimuli in other modalities or from
more rostral CBF neurons. CBFt sound responses are not stable, but instead are rapidly and selectively
enhanced for threat-predicting sounds during Pavlovian and instrumental learning paradigms. Thus, our
studies of the tail region suggest a different model for cholinergic modulation of cortical sound processing in
which the ACtx is continuously bombarded by sound-triggered acetylcholine (ACh) surges that reorganize
during learning to highlight relevant sounds and guide cortical receptive field plasticity. Here, we describe three
specific aims for the coming project period that will illuminate how the CBFt regulates thalamocortical sound
processing, perceptual awareness of sound, and associative plasticity during auditory learning. Studies in Aim
1 will test an inverted-U hypothesis for cholinergic modulation of sound processing, which holds that sensory
tuning in the primary ACtx (A1) and TRN become imprecise and unreliable during transient peaks and troughs
of local endogenous ACh release. Further, we predict that these effects can be accounted for – in part – by the
particularly strong influence of CBFt-mediated ACh release on A1 layer 6 corticothalamic neurons, as tested by
studies in both intact and acute thalamocortical brain slice preparations. Aim 2 will extend these ideas to the
behavioral domain by showing that occasional lapses in thalamocortical encoding and perceptual awareness of
target sounds (i.e., miss trials) can be attributed to stochastic peaks and troughs in CBFt-mediated ACh levels
immediately preceding target sound onset. Aim 3 will test the hypothesis that enhanced CBFt responses to
sounds associated with aversive – but not appetitive – reinforcement is sufficient to shift A1 sound
representations from a mode of net stability to heightened plasticity that supports associative auditory learning.
These hypotheses will be tested through the combined application of genetically encoded ACh sensor imaging,
optogenetics, multi-regional single unit recordings, and 2-photon calcium imaging of CBFt or NB axons in
awake transgenic mice during voluntary and involuntary behavioral reporting of sound perception.

Public health relevance
The base of the mammalian forebrain is studded with clusters of cholinergic neurons that regulate arousal, environmental awareness, and memory consolidation. Here, we focus on an overlooked cluster of these neurons – the tail of the basal forebrain - that have unusual response properties and may regulate our ability to perceive and learn from environmental sounds. Research on the function of basal forebrain tail neurons could identify new therapeutic avenues for the rehabilitation of sensory disorders and illuminate the connection between hearing abilities, dementia, and neurodegenerative diseases.